Project 2: Lung cancer screening Awareness Targeted and Tailored to Increase sCrEening (LATTICE)

Lung cancer is the most common cancer in the US and kills more Americans than the next top three cancer
types (breast, prostate and colorectal) combined. Currently, 85% of lung cancers are diagnosed when they have
already metastasized, resulting in a poor five-year survival of 17%. Fortunately, radiographic screening for lung
cancer using Low Dose Computerized Tomography (LDCT) is highly effective at identifying lung tumors at an
early stage and is known to improve lung cancer mortality by 20%. Unfortunately, ~10 years after the guidelines
released, LCS utilization is woefully low, at <6%. Most individuals eligible for LCS are unaware of or confused
or misinformed about (i) how lung cancer screening is performed, (ii) benefits and associated risks of screening,
and (iii) causes of and associated risk factors for developing lung cancer. Although previous work has highlighted
the effects of communication tools in cancer screenings, what is not known is the availability of geographically
tailored awareness and education implementation strategies. Therefore, there is a need to address these issues
by developing and delivering regionally tailored awareness strategies. Our overall objective in this application is
the development and delivery of a geographically tailored educational strategy to improve early detection of lung
cancer in the states of Alabama and Georgia. Aim 1 will adapt and geographically tailor existing lung cancer
screening education strategies. We will adapt existing lung cancer screening education materials using
Resnicow’s framework will be used to address unique social and cultural factors influencing this group’s
screening participation. Aim 2 will pilot test educational strategy and refine based on input from Community
Advisory Board (CAB). We will use Group Concept Mapping with the CAB to determine salient social
determinants of lung cancer screening and “map out” salient social factors of early detection educational
strategy, as conceptualized by the participants themselves. This proposed work will aid in developing and
delivering a geographically tailored educational strategy to improve early detection of lung cancer in the states
of Alabama and Georgia.

Public health relevance
Disease stage at the time of diagnosis is the most important determinant of prognosis in lung cancer. Despite demonstrated effectiveness of LCS with LDCT in reducing lung cancer mortality, early detection continues to elude populations with the highest risk for lung cancer death. This work is expected to be significant because an effective community-centered, geographically tailored awareness strategy can increase long-term smokers’ awareness of and education about lung cancer and screening, facilitate informed choices and lay the foundation for future patient- level research on LCS.